The Influence of Childhood Adversity on Psychotherapy Skill Acquisition in Adolescent Depression - Supplement

PROJECT SUMMARY/ABSTRACT
Nearly 60% of youths in the U.S. are exposed to childhood adversity, including violence exposure, abuse,
neglect, loss of caregivers, and living in poverty. Global and national data indicate that adversity accounts for
30-50% of the risk for depression onset from childhood through adolescence, and response to evidence-based
front-line interventions (e.g., cognitive behavioral therapy [CBT] and antidepressants) is notably poor among
adversity-exposed youths. Research demonstrates that exposure to adversity disrupts general learning
processes, including higher-order cognitive processes (i.e., cognitive control). Learning impairments may impede
one of the most common and critical intermediary treatment processes across evidence-based psychotherapies:
the acquisition of therapy skills. This proposal uses an innovative approach to investigate childhood adversity
exposure as a predictor of skill acquisition for the most commonly implemented CBT skill with depressed youth,
cognitive restructuring. To refine interventions and optimize effectiveness, it is critical to identify how existing
treatments break down. This study will use a repeated-measures, multiple levels of analysis approach to assess
acquisition and retention of an experimenter-introduced cognitive restructuring skill over six months, among
depressed adolescents with population-level variability in lifetime adversity exposure (n=90). The candidate
proposes to investigate associations between adversity exposure and learning-related cognitive control
processes in the context of adolescent depression (Aim 1). Adversity exposure and cognitive control will be
examined as direct predictors of CBT skill acquisition, and an indirect pathway from adversity to skill acquisition
through cognitive control will also be examined (Aim 2). The candidate will further explore key characteristics of
adversity, namely the type (threat of harm versus deprivation of resources) and developmental timing of
exposure, as unique predictors of skill acquisition (exploratory Aim 3). The proposed K23 builds on the
candidate’s prior training in environmental and biobehavioral risk for psychopathology, and evaluation of
treatment effectiveness, with new training in 1) experimental therapeutics; 2) developmental conceptualizations
of childhood adversity, and 3) behavioral assessments of cognitive and affective learning processes. The
Department of Psychiatry at the University of Pittsburgh is an ideal scientific setting to achieve the proposed
career development goals, and the candidate will receive training from a team of mentors (Drs. Goldstein, Luby,
and Sheridan) and consultants (Drs. Forbes, Lindhiem, and Wallace) with expertise in target-focused intervention
research, child adversity and risk for poor clinical course in youth depression, and developmental cognitive and
affective science. The near-term goal of this award is to identify sensitive markers of depression intervention
response among adversity-exposed youths. This will provide a crucial vehicle to advance the candidate’s
overarching career objective: to develop a translational research program leveraging advances in basic science
to inform experimental therapeutics for personalizing and optimizing depression treatment in high-risk youths.

Public health relevance
PROJECT NARRATIVE Childhood adversity is associated with higher risk of youth-onset depression, disruptions in cognitive and learning processes, and poor response to front-line depression treatments. Poor treatment response in adversity-exposed youths is largely unexplained, and the proposed research will be the first to examine how adversity and related impairments in learning processes (i.e., sub-processes of cognitive control) influence the acquisition of therapy skills, a primary treatment process in evidence-based psychotherapies. The research strategy presents a critical first step in identifying how childhood adversity impacts treatment effectiveness, and it has the potential to inform intervention research aimed at tailoring and optimizing depression interventions in this vulnerable youth population.